Leveraging Machine Learning for Dynamic Prediction and Mitigation of Acute Kidney Injury after Cardiac Surgery

Acute kidney injury (AKI) is the most frequent complication after cardiac surgery and is associated with a
multitude of adverse outcomes including increased short- and long-term mortality, length of stay, and hospital
cost. Early prediction of AKI can enable targeted interventions involving volume, inotrope, and pressor
management that have been shown to improve outcomes and mitigate injury. Presently, AKI is identified via
clinical parameters such as urine output and serum creatinine, however these represent late findings often
manifesting after the treatment window. Furthermore, current methods for estimating AKI risk provide static
predictions that are of limited clinical value in the dynamic postcardiac surgery critical care environment. In our
preliminary work, our team recently demonstrated that ensemble machine learning (ML) analysis of electronic
medical record (EMR) intensive care unit (ICU) data enables the early and accurate prediction of AKI after cardiac
surgery. The objective of this proposal is to leverage ML based analysis of EMR data to develop new clinical
decision support (CDS) tools to monitor AKI risk and suggest personalized, timely, data-driven interventions that
prevent or mitigate morbidity. Our central hypothesis is that ML models can facilitate clinical decision making
by accurately and dynamically predict AKI from routinely collected EMR data and enhancing clinical decision
making by quantifying risk reduction of therapeutic interventions. The rationale underling this proposal is that
completion will yield a clinically translatable ML-enabled CDS tool that can identify AKI earlier than clinical
detection and effectively support clinical decision making to mitigate AKI after cardiac surgery. The central
hypothesis will be tested by pursuing three specific aims: 1) develop personalized ML algorithms for real-time
early detection of AKI; 2) develop interpretable ML algorithms for therapeutic interventions to mitigate AKI; 3)
prospectively validate model predictive performance and efficacy as CDS tool. The proposed project is
innovative in the application of novel ensemble ML techniques to analyze our unique Baylor College of Medicine
Cardiac Surgery Database that combines validated clinical registry data with time series EMR data
(hemodynamic, medication, and laboratory) during the pre-, intra- and post-operative phases of care. The
proposed project is significant because early identification and optimized management of AKI will improve
outcomes for patients with this highly prevalent and morbid complication. Furthermore, successful measurement
of model efficacy in clinical practice will legitimize ML-enabled CDS systems thereby improving clinician buy in,
as heretofore few ML-enabled CDS tools have been evaluated in real-world conditions and even fewer clinically
implemented. This work will provide a framework for development and translation of ML-enabled digital health
solutions that can be applied to a variety of clinical scenarios. The expected outcomes of this work are 1) the
early and accurate identification of AKI; 2) the data-driven identification of optimal management strategies to
mitigate AKI; 3) validation of ML-enabled clinical decision support systems in the clinical environment.

Public health relevance
Acute kidney injury (AKI) after cardiac surgery occurs in 20% of patients and yields a 5-fold increase in mortality and 3-fold increase in hospital cost. Early prediction would enable targeted interventions that can improve outcomes, however, prior risk estimation methods have relied on static risk predicton which have limited value in the dynamic post-operative environment and have not proven to be beneficial in clinical practice. This proposal develops an innovative clinical decision support tool by leveraging machine learning of time-varying electronic medical record data to dynamically monitor patient-specific risk of kidney injury after surgery and suggest personalized, timely, data-driven interventions that prevent or mitigate morbidity.